Automated Digital Uroflowmetry For Office and Home Use

Abstract
Uroflowmetry is the most common urodynamic test performed by urologists to assess the function of the lower
urinary tract. This simple non-invasive study measures urinary flow rates and when summarized graphically
offers insights into various types of lower urinary tract symptoms. Current systems call upon a patient to void
into a commode with a funnel to direct the flow of urine into a vessel placed on a digital scale which in turn
drives its output into a processor. The processor is connected to a printer which produces summary data
such as voided volume, peak flow, average flow, total void time, as well as a graphical representation of the
flow curve anywhere from 20-30 seconds after the void is initiated or completed. The physician or their
assistant will then empty the vessel, and the system can be used again. Traditionally the paper containing the
printed collected data was filed into a paper chart. Today this tracing is taped to a 2nd paper containing the
patient’s name and medical record number, and this is scanned into the electronic record as an image and the
data become non-searchable. Given this labor intense process, conventional uroflowmetry is ripe for
disruptive innovation.
We offer a hardware and software solution to these logistical problems. At this time our patent pending
prototype uroflowmeter offers the following benefits: 1) it can be used with any regular toilet (meaning it can
be used in an office setting or at home, and it can be used by both males and females), 2) it empties itself,
and 3) the data are acquired in real time, and collected on a smart phone or tablet. In this application we seek
support to develop the software that will allow this device to drive its data elements and the graphical
summary into a set flowsheet in the electronic medical record where all uroflows will be stored. This will allow
for a physician to review multiple flows over time to monitor a patient’s progress without having to open up
each individual image. Once this system is fully operational we envision this system being used in office and
home settings, and playing a role in drug trials that assess lower urinary tract symptoms. The instantaneous
detection of flow rate also means it has the potential for future applications in biofeedback training for selected
patients with specific lower urinary tract symptoms.

Public health relevance
Lay Summary Uroflowmetry or the measurement of the speed of urine flow rates remains the most common tool by which urologists can assess the health of the lower urinary tract. Current methods of measurement are time consuming, rely upon paper records, and are limited to the office. We offer a new system that can be used on any regular toilet in the office or home that will transmit the flow data wirelessly into the electronic medical record.